EXPANDING MHAS RESEARCH INFRASTRUCTURE WITH HISTORICAL CLIMATE AND LIFETIME WORKPLACE ENVIRONMENTAL EXPOSURES INFLUENCING INEQUITIES IN AD/ADRD

PROJECT SUMMARY/ABSTRACT
This project will merge longitudinal the Mexican Health and Aging Study (MHAS) data with that on climate and
classify workplace environment exposures. This will yield a dataset offering new insights on how climate and
workplace environment affects trajectories for Alzheimer’s disease and Alzheimer’s disease and related
disorders (AD/ADRD). Because the MHAS has been collected longer than any other similar survey in the
developing world, the resulting data set will help generate important findings on the growing proportion of persons
in low- and middle-income countries living with AD/ADRD. The project has two specific aims. Its first aim is to
expand the ability of the MHAS to support research on exposome and its relation to AD/ADRD with lifetime
climate and occupational exposures. We will accomplish this by linking MHAS data to climatological data
(monthly temperature and pluvial precipitation data since 1952 by municipality and state), data on hurricanes
(including their impact), data on the effects of climate change (state-level data on soil erosion, forest fires, and
natural disasters), data on national and state policy changes regarding laws and regulations on toxic emissions
and climate change, and by classifying respondents’ lifetime and current jobs by workplace environmental
exposure. Its second aim is to foster research on the influence of environmental exposures, early life
disadvantages, and lifetime occupation on AD/ADRD health disparities. We will do this by documenting and
disseminating the new data sources with MHAS linkages on the MHAS website platform in English and Spanish.
The CeASES ADRD website and Dissemination Core will help outreach a broader audience and increase the
visibility of these new products. We will also illustrate how to use the new variables in assessing determinants of
cognitive function and AD/ADRD. These new products will also help researchers leverage recent MHAS
questions on housing proximity to toxic or noisy environments as well as information from a hair biomarker
collected in 2018 on exposures to heavy metals such as lead, mercury, and titanium. The new linked data files
will help promote new research on exposome among understudied vulnerable older adults.

Public health relevance
PROJECT NARRATIVE Beyond traditionally analyzed economic disadvantages, climate and workplace environment exposures may explain health inequities in AD/ADRD. This project will expand the Mexican Health and Aging Study (MHAS) research infrastructure by linking new historical climate measures and classifying lifetime workplace environmental exposure and contextual data.